Cumulative Demographic and Health Effects of Climate Exposures

PROJECT SUMMARY
This project will study how exposure to climatic variability (i.e., temperature and precipitation anomalies) during
different phases of the life course, from early childhood through adulthood, affect older adults’ health,
economic status, and migration behaviors. We draw on data from the Indonesian and Mexican Family Life
Surveys to measure three health outcomes (body mass index, hemoglobin, and blood pressure), consumption
expenditures, and lifetime migration status among adults aged 50+ years in Indonesia (~36,000 observations
from ~17,000 individuals) and Mexico (~19,400 observations from ~13,100 individuals). We link these
demographic records to high-resolution climate data, and measure individuals’ climate exposures during early
childhood (ages -1 to 5), adolescence (ages 12 to 18), and early adulthood (ages 19 to 25). We fit a series of
fixed effects regression models to measure the independent effects of climate exposures during the three focal
critical periods, while controlling for relevant demographic characteristics and spatial and temporal
confounders. We then evaluate whether and how climate effects vary by age, sex, and rural (urban) residence
at birth, all of which we expect to be correlated with climate vulnerability. Our third set of analyses evaluate
whether exposure to recurring shocks from early childhood through adulthood have compounding and (or)
cumulative effects on health in older adulthood. We also perform a series of supplemental analyses that test
the robustness of our findings to alternative data and measurement decisions and compare the effects of
earlier-life and contemporaneous shocks on health in later life. This study provides new evidence about the
links between climate change and older adults’ demographic and health outcomes in the developing world,
where the severity of climate change and extent of population aging are expected to increase in the decades
ahead.

Public health relevance
PROJECT NARRATIVE Global climate change is expected to have significant consequences for the health and wellbeing of affected populations, especially for individuals who are older and (or) economically marginalized. We use demographic and health surveys from Indonesia and Mexico, combined with high-resolution climate records, to measure the effects of climate exposures during early childhood, adolescence, and early adulthood on health, economic, and migration outcomes in older adulthood.